Role of tissue-nonspecific alkaline phosphatase in dentoalveolar development and disease

PROJECT SUMMARY/ABSTRACT Tissue-nonspecific alkaline phosphatase (TNAP) is perhaps the most critical enzyme for skeletal and dental mineralization, reducing local concentrations of the mineralization inhibitor, inorganic pyrophosphate (PPi). Loss- of-function mutations in the TNAP-encoding ALPL gene cause hypophosphatasia (HPP), an inherited error-of- metabolism that causes rickets, osteomalacia, and bone fragility. Dental defects accompanying HPP are lifelong difficulties, the most common being premature tooth loss. Dental tissues are among the most sensitive to HPP, as dental manifestations are nearly universal in HPP subjects. The recently approved TNAP enzyme replacement therapy (ERT) shows great promise for improving skeletal mineralization and overall health, however, critical gaps in knowledge present obstacles to understanding pathological mechanisms and successful treatment of HPP dental disease. The long-term goals of our studies are to better understand how HPP affects dentoalveolar tissues and use that knowledge to direct evidence-based treatment, also informing about the larger functional importance of TNAP in development and potential for use in regenerative therapies. To begin to accomplish these goals, our short term aims are: for the first time to directly and quantitatively analyze effects of HPP on dental tissues in human teeth, and to use a novel mouse model of HPP to investigate efficacy of ERT on dentoalveolar tissues based on time of intervention. Our central hypotheses, based on previous reports and our preliminary data, are that all dental hard tissues are affected by HPP in a manner correlated to severity of skeletal/systemic/biochemical changes, and that ERT can correct the course of dentoalveolar mineralization and tooth attachment in HPP. Our hypotheses will be tested by two Specific Aims: (1) Quantify HPP dental mineralization defects and correlate with other phenotype manifestations in humans and mice; and (2) Analyze effects of enzyme replacement therapy (ERT) on human teeth and HPP mouse dentoalveolar development and function. Innovations in our study design will address gaps in knowledge related to HPP and TNAP in dentoalveolar development and function. These innovations arise from coordinated application of novel tools and unique opportunities, including: the first use of high resolution micro-CT and histological analysis on a large collection of teeth from HPP subjects, also correlating dental data to musculoskeletal, biochemical, and genetic analyses in that cohort; the first analysis of teeth from HPP subjects treated with ERT; optimization of a novel mouse model of HPP to test ERT at timed interventions at later more clinically relevant ages; first use of an orthodontic tooth movement model to evaluate periodontal response in ERT-treated HPP mice; and first use of mechanical testing to evaluate periodontal function in treated genetically modified mice. Future Research Plans: Experiments will provide data for continued work on HPP and TNAP, including etiopathologies of dental and skeletal defects in HPP mouse models, evaluation of ERT efficacy for ameliorating HPP dental defects in human subjects, and wider employment of recombinant TNAP in regenerative therapies.

Public health relevance
PROJECT NARRATIVE Loss-of-function mutations in the ALPL gene encoding tissue-nonspecific alkaline phosphatase cause hypophosphatasia (HPP), an inherited error-of-metabolism that severely affects skeletal and dental mineralization. Dental tissues are among the most sensitive to HPP, as dental defects are nearly universal in HPP subjects and cause lifelong difficulties, including premature tooth loss. Despite the recognized negative effects on orodental health, critical gaps in knowledge present obstacles to understanding pathological mechanisms and successful treatment of HPP dental disease. This project is designed to increase understanding of the dental effects of HPP through analysis of human primary teeth of individuals with HPP and use of novel mouse models of HPP to study pathological mechanisms as well as treatment effects.